Western Mining Safety & Health Training Resource Center: Facilitating Research to Practice through Learning Laboratories

PROJECT SUMMARY / ABSTRACT
In our prior Miner Safety and Health Training Programs - Western United States (U60) grants, we developed the
Learning Laboratories (LLs) program, which is an industry-academic collaboration involving three universities
and more than 20 mining organizations and operators representing over 20,000 mine workers in the Western
US. The LLs program provides needs-specific training resources and mentorship for miners, trainers,
supervisors, and health and safety (H&S) professionals across all sectors of the industry. Operators participating
in the LLs program have shown measurable improvements in H&S outcomes, including reductions in both
average injuries and days lost, up to 23.6% and 72.5%, respectively. Building upon these successes, we will
expand our LLs program through three specific aims: 1) Provide new pathways for training and research through
collaborative learning laboratories. Our LLs program offers a powerful mechanism for collaboration between
researchers, safety professionals, and industry trainers. The program will be expanded to meet all core elements
of NIOSH’s Research to Practice (R2P) initiative. Specifically, we will increase partnerships with trainers serving
contractors, small operators, and other underserved groups and MSHA State Grants programs. We will work
with investigators in academia and at NIOSH to identify industry needs, deploy new and existing training
materials, facilitate synergistic research agendas, and evaluate outcomes. We will enhance technology transfer
by streamlining deployment of new computer and app-based materials to industry partners for use in training
and continued development. We will improve communication among LL partners through meetings, workshops,
and an online forum. We will facilitate evaluation through mentorship and a cloud-based data collection and
analysis platform. 2) Improve health training. By adding new health modules to our training materials, many
NIOSH National Occupational Research Agenda (NORA) cross-sector topic areas will be addressed, including
chronic disease, musculoskeletal health, hearing loss prevention, respiratory health, and heat strain. We will also
incorporate Total Worker Health topics such as mental health, substance abuse, and fatigue. 3) Develop, extend,
and integrate a continuum of training resources. Successful training products developed by our program, NIOSH,
and LL partners will be upgraded to incorporate new content, capabilities, and interoperability. We will develop
resources addressing all levels of trainer capability, from easily integrated tabletop games to computer-based
synthetic learning environments (SLEs). We will improve the accessibility of training and evaluation technologies,
particularly for trainers serving smaller operators and at worksites lacking sophisticated computer hardware,
using app-based mobile games and streaming services. Intermediate outcomes will include: 1) Improved H&S
practices; 2) Workers empowered through active learning; 3) Increased sharing of effective training programs;
and 4) An increased number of competent miners, trainers, supervisors and H&S personnel. The end outcomes
of the program will include H&S culture change and reductions in mining injuries, illnesses, and fatalities.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to improve mining safety and health training in the western United States and support efforts to reduce mining injuries, illnesses and fatalities. Despite continued improvements over time, mining injuries and fatalities continue to occur in the mining industry, and reducing occupational illnesses remains challenging. Building on our past mine training grants, we will expand and enhance the Learning Laboratories program to be more responsive to the specific health and safety challenges that each operator faces and greatly improve collaboration through three-way partnerships with industry, academia, and government agencies.